A smart wearable contact microphone patch for extended and remote monitoring of lung functions

Project Summary
Respiratory diseases (RDs) like asthma and chronic obstructive pulmonary disease (COPD) are among the
leading causes of death in the US and impose a major economic burden on the healthcare system. Early
detection and monitoring of a patient’s lung function, respiratory abnormalities and their exacerbations plays a
crucial role in evidence-based disease management to reduce morbidity, mortality, and cost associated with
COPD readmissions. Current monitoring and diagnostic methods rely on costly and time-consuming clinical
visits, discouraging preventative screening. Patients without severe symptoms often wait until they become
chronic and need more specialized care. In addition, diagnosis often relies on detection of intermittent abnormal
lung sounds and respiration patterns, which would benefit from prolonged recordings outside the clinic setting.
Auscultation is a well-established non-invasive diagnostic method for RDs through detection of lung sounds.
Stethoscopes have been used by physicians for over two centuries, but they are unsuitable for extended and
remote monitoring of respiratory activity due to their large form-factor and dependence on continuous listening
and interpretation by an experienced physician. In this project, we aim to create a smart easy-to-use low-profile
wearable device for accurate detection and quantification of adventitious lung sounds as well as breathing
abnormalities via prolonged mechano-acoustic measurements without relying on continuous listening by a skilled
physician. To achieve this goal, StethX proposes to develop a battery-powered wireless wearable patch with a
small footprint close to a typical band-aid utilizing a novel hermetically-sealed low-noise and low-power chip-
scale contact microphone technology that is insensitive to airborne ambient sound.
The wearable patch will be easy to apply and can be comfortably worn at multiple locations for prolonged
continuous auscultation measurement, accompanied with machine learning algorithms for automatic detection
and classification of wheezes, crackles, and breathing patterns. The contact microphone patch is immune to
airborne ambient sounds as it only picks up the subtle vibrations of a surface it is mounted on, with high
sensitivity. The patch can simultaneously record respiratory sounds in a wide frequency range up to 10 kHz,
along with low-frequency respiratory rate, heart rate, breathing pattern, and physical activities and position of the
wearer (DC and low-frequency contents). Performance of the miniaturized wearable patch will be optimized and
benchmarked against state-of-the-art digital stethoscopes for feasibility assessment. The feasibility study done
in Phase I of the project will pave the way for large-patient-pool evaluation and commercialization of the
technology in Phase II. Once commercialized, our wearable solution is expected to greatly improve the
accessibility, accuracy, and comprehensiveness of asthma and COPD diagnosis with prolonged recording and
a pathway to automatic pathological signal detection by digitizing respiratory sound signals and correlating it with
heart sounds and chest motions.

Public health relevance
Project Narrative Respiratory disorders such as chronic obstructive pulmonary disease (COPD) and asthma are among the leading causes of disability and death globally, which are currently widely underdiagnosed, undertreated, and often undermanaged over time. In this project, we will develop an easy-to-use smart wearable lung monitor based on a proprietary contact microphone technology to enable extended monitoring and analysis of lung sounds and breathing function with a higher sensitivity than medical-grade digital stethoscopes and in a significantly smaller form-factor. The wearable patch developed in this project aims to help with remote monitoring of patients outside of the hospital, facilitating early diagnosis, and reducing the risks and cost associated with management of respiratory diseases.